Manipulating nucleic acids: applications in RNA biosensing, single-molecule analysis, and DNA nanotechnology

Project Summary/Abstract
Our vision is to develop, apply, and advance new technologies in the broad thematic program of the manipulation
of nucleic acids. The research largely focuses on RNA-based applications, which is both driven and enhanced
by our unique environment at The RNA Institute, enabling easy collaboration and cross pollination of ideas and
techniques across fields. The importance of RNA and RNA technologies has never been clearer, with a pandemic
RNA virus (SARS-CoV-2) being managed by RNA biosensing tools and mRNA-based vaccines. It is now well
accepted that RNA plays a complex role in biology that goes far beyond the “central dogma”. Elucidating many
RNA functions and biomedical applications requires investment in technology development. In this proposal,
carried out over the next five years, we aim to advance technology in three main areas: 1) DNA nanoswitches
as programmable nanoscale reagents for reporting molecular interactions, 2) the Centrifuge Force Microscope
(CFM) for high throughput single molecule probing and analysis, and 3) DNA nanotechnology for applications in
drug delivery and sensing. Each of these areas builds on our strengths and past performance.
In the first area, we use DNA nanoswitches as “smart” reagents that change conformation upon binding a target
molecule. Building on past success, we will expand this innovative method to enable low cost and simple RNA
detection, quantification, and purification for various RNAs. These include detection of RNA modifications,
detection of regulatory lncRNAs, and purification of RNA and RNA complexes. In the second area, we will
develop and execute assays for the Centrifuge Force Microscope (CFM) in RNA and DNA interaction analysis
and RNA structure-function probing. In particular, we will investigate fundamental thermodynamics of weak
interactions in DNA and RNA, develop a new method for single-molecule structural probing of RNA, and study
the structure-function relationship of a pre-clinical therapeutic ribozyme. In the third area, relatively new for our
lab, we expand work to analyze and develop DNA nanotechnology for applications including drug delivery.
Specifically, we are interested in understanding and “programming” biostability into DNA nanostructures, and in
coordinating chemical attachment and triggered release of molecular payloads from DNA nanostructures.
This proposal aims to carry out ambitious research and development plans performed within the context of
several biomedical projects. The impact of the developments will extend beyond the individual projects, as our
core technologies and methods are increasingly adopted by other groups. In the first MIRA term we have proven
our ability to develop impactful technology and advance innovative science on several fronts. In this second term,
we aim show sustainability of our research endeavors, solidifying our niches, maintaining high productivity, and
ultimately producing knowledge and tools to benefit the scientific community.

Public health relevance
Project Narrative RNAs perform important regulatory functions that make them attractive as disease biomarkers, therapeutics, or therapeutic targets. This project is aimed at developing user-friendly new technologies for the detection and analysis of various RNAs. Ultimately, these simple and inexpensive techniques will accelerate the pace of discovery in RNA research to the benefit of human health.